SECONDARY METABOLITE(S) SECRETED BY POLYMORPHIC MICROBIAL POPULATIONS

The objective of this project is to investigate microbial population structure in complex mixed organism systems by examining secreted secondary metabolites. Mass spectrometry (FAB-MS, MALDI-MS) has been used to identify characteristic metabolites of different organisms.